Clinical Trial Readiness for Posterior Cortical Atrophy Syndrome

Abstract
The overall goal of this project is to address the critical unmet need for longitudinal data from clinical
outcome assessments (COAs) and plasma biomarkers for the rare syndrome of posterior cortical atrophy
(PCA) to enable clinical trial readiness with currently available candidate therapeutics. PCA was described in
1988 in five patients with progressive dementia that began with higher-order visual dysfunction and relative
sparing of `memory, insight, and judgment' with a predominance of atrophy in the parieto-occipital regions. We
now understand that Alzheimer's disease (AD) is the underlying pathology in up to 100% of patients and onset
usually occurs at a younger age, between age 50 and 64 years. The visual-predominant phenotype and lack of
longitudinal data combine to impede clinical trial design for PCA. Notably, widely used COAs for AD clinical trials
rely on changes in memory and domains that are relatively spared in PCA, and assessments of higher-order
visual impairment are very limited in COAs in AD trials. For these reasons, PCA presentations of AD do not meet
the inclusion criteria for traditional AD clinical trials. To overcome barriers to inclusion and to clinical trial design,
we will enroll 25 people with PCA, defined by 2017 diagnostic criteria, and longitudinally assess, over one year
the following outcomes 1) one patient-reported and one informant-reported PCA-specific COA, 2) a novel PCA
COA staging method using a probabilistic ordering of decline on 13 tasks that are inclusive of higher-order visual
functions, 3) AD-COAs widely used in AD clinical trials, and 4) plasma biomarkers of neurodegeneration and AD
pathology. In Aims 1 and 2, we will measure the responsiveness of COAs to PCA progression and the reliability
and internal consistency of an informant-based PCA-specific COA. The convergent validity and responsiveness
of the novel PCA staging COA will be assessed in Aim 2. Lastly, we will evaluate the responsiveness of plasma
biomarkers to clinical changes in exploratory Aim 3 in anticipation of the future use of biomarkers as surrogate
markers of treatment impact in a clinical trial. The establishment of these longitudinal benchmark measures using
COAs and plasma biomarkers will serve as an essential foundation for enabling PCA clinical trial readiness with
promising and currently available candidate therapeutics.

Public health relevance
Project Narrative Upon successful completion of the proposed research, we expect our contribution to address the critical unmet need for longitudinal data from clinical outcome assessments and plasma biomarkers for clinical trial readiness for the rare disorder of Posterior Cortical Atrophy (PCA). This contribution will be significant because it will establish the essential foundation necessary to successfully design and recruit participants with PCA for future clinical trials with currently available candidate therapeutics. Longitudinal investigations of PCA will also allow us to broaden our understanding of the heterogeneous nature and pathophysiology of Alzheimer's disease, which is especially relevant to the development of new approaches to treatments for a major public health issue.